MATRIX BASED MINERAL ENAMEL-BIOMIMETICS

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to provide insight into the structure, dynamic interactions and multifunctionality of
the enamel protein ameloblastin (Ambn), and hence to contribute to the fundamental knowledge as relevant
to enamel biomineralization. Ambn is multifunctional with critical roles in the regulation of mineral formation,
cell differentiation, cell polarization, and cell–matrix adhesion. We recently identified a novel, highly-conserved
amphipathic helix (AH) cell binding domain, located within the sequence encoded by exon 5, and adjacent to
the C-terminus of the well-established Ambn self-assembly/co-assembly domain. Our preliminary data using
two novel CRISPR-Cas9 gene editing mouse models in which different parts of the AH domain are deleted,
show that the AH plays essential roles in amelogenesis. Analysis of enamel from homozygous strains with
different deletion mutations on AH domain revealed distinct enamel phenotypes that exhibited
hypomineralization with different severity. These observations along with recent published reports from our
laboratory have led us to hypothesize that Ambn is a matricellular protein, and its complex role in
amelogenesis relies on a multitargeting property centered in the region of the sequence encoded by exon 5.
Ambn interacts with ameloblast cells via the AH domain and functions to anchor the mineralizing extracellular
matrix to enamel-forming cells. To test our hypothesis, we seek to implement a mechanistic approach to
interrogate the structure and function of the multitargeting motif in Ambn, including the AH domain. This will
be achieved by 1) conducting a detailed investigation of enamel formation in two novel Ambn AH mutant
mouse models in vivo (Aim I), 2) examining Ambn-cell interactions in 3-D cell culture (Aim II), and 3)
completing an in vitro investigation of interacting domains in the Ambn sequence involved in its self-assembly,
amelogenin (Amel), other potential targets, and cell membrane interactions (Aim III). Overall, our studies will
advance understanding of the molecular function of Ambn in enamel biomineralization and of inherited enamel
disease, elucidate genetic factors leading to caries susceptibility, and contribute to our efforts to regenerate
dental hard tissues.

Public health relevance
PROJECT NARRATIVE Dental caries is a complex infectious disease with multiple genetic and environmental risk factors posing a major health burden globally. The goal of this proposal is to provide insight into the structure, dynamic interactions and multifunctionality of ameloblastin protein, and hence to contribute to the fundamental knowledge as relevant to enamel formation, and to understanding of inherited diseases of enamel and genetic factors that affect caries susceptibility. Insight gained from the proposed studies will contribute to biomimetic efforts to regenerate and reconstruct dental hard tissues.